Interpretable Deep Learning for Analyzing Brain Development Heterogeneity with Personalized Functional Networks Across Multi-Site Data

ABSTRACT
Intrinsic functional connectivity magnetic resonance imaging (fcMRI) is a powerful tool for understanding brain
function and development. Despite significant progress in modeling personalized functional networks (PFNs)
and leveraging machine learning (ML) to predict brain-behavior relationships, challenges persist, including the
heterogeneity of brain development, the difficulty in characterizing diverse PFN patterns, site effects in multi-
site datasets, and the limited interpretability of deep learning (DL) models. To address these challenges, this
project aims to develop, validate, and disseminate tools for computing and characterizing heterogeneous
PFNs, harmonizing multi-site fcMRI data, and building interpretable prediction models. These models will
capture PFN patterns linked to variations in brain development and psychopathology in youth. Specifically, we
will develop a novel self-supervised DL method to identify distinct biotypes of individual variation in fcMRI data
and compute biotype-specific PFNs using a mixture-of-experts approach. We will also develop a robust self-
supervised DL method to harmonize multi-site fcMRI data and compute PFNs, employing a test-time
adaptation (TTA) strategy. Additionally, we will develop an interpretable DL method to characterize and predict
cognition and psychopathology based on PFNs, leveraging a generalized additive model (GAM) framework
with a prototype learning mechanism. The tools will be developed and validated using data from the
Adolescent Brain Cognitive Development (ABCD) Study, the Philadelphia Neurodevelopmental Cohort (PNC),
the Healthy Brain Network (HBN), and the Lifespan Human Connectome Project in Development (HCP-D). The
algorithms will be released as a user-friendly toolbox with source code and standalone programs on GitHub
and DockerHub. This project will revolutionize our understanding of brain development, enhance our
understanding of individual brain development, and pave the way for more effective, personalized treatments in
diverse clinical settings.

Public health relevance
NARRATIVE This project aims to revolutionize our understanding of brain functional development by developing advanced AI tools based on large-scale functional MRI datasets. We will identify individual brain patterns, harmonize brain scans across studies, and build interpretable AI models to predict cognitive and psychiatric traits, ultimately leading to more accurate diagnosis and effective treatments for brain disorders.